Dissemination and Outreach Core

Effective dissemination of public health research involves a range of products, methods, and strategies tailored
to diverse stakeholder audiences at the community, academic, practice, and policy levels. The Dissemination
and Outreach Core of the AJ Drexel Autism Institute (AJDAI) Autism Centers of Excellence (ACE), ‘Public
Health and Autism Science advancing Equitable Strategies across the life course (PHASES)’, integrates
stakeholder engagement, training, and outreach across four Projects to facilitate bidirectional communication
between Center investigators and members of the community. Dissemination and implementation strategies
are embedded as core components of the public health research process in PHASES from designing studies
and developing research questions through data collection, interpretation of research findings, and
disseminating findings to scientific and lay audiences. This will be accomplished through addressing the
following aims: (1) Identify and execute multiple dissemination approaches, including innovative policy
outreach and community-driven dissemination to expand the translation and dissemination of research-based
findings to the broader scientific, policy, and stakeholder communities. (2) Develop a proven community
engagement model, called the Community Partnered Participatory Research (CPPR) model, to establish two-
way power sharing communication between investigators and community stakeholders from under-resourced,
under-represented communities and organizations. (3) Implement rigorous, evidence-based inclusion and
training strategies to engage undergraduate, graduate students, post-doctoral fellows, and early stage
investigators in diverse aspects of research and community stakeholder engagement. The AJDAI, as the first
public health-focused autism research center in the country, is uniquely positioned to conduct the work of the
PHASES ACE Center. The Dissemination and Outreach Core will capitalize on existing infrastructure at the
AJDAI to support PHASES Center activities and align with the cross-cutting theme in the NIH strategic plan to
address public health challenges across the lifespan.